A Multi-Omics Approach to Discover Metabolic Critical Quality Attributes for Cardiomyocyte Biomanufacturing

PROJECT SUMMARY
Human induced pluripotent stem cells (iPSCs) provide a promising source of patient-specific cardiac cells. Our
team has pioneered development of protocols to differentiate iPSCs to cardiomyocytes (iPSC-CMs) but these
cells lack mature, adult-like phenotypes. One hallmark of CM maturation is a transition from glycolysis and
glucose oxidation to fatty acid oxidation as the dominant metabolic pathway, among other metabolic changes.
Our premise is that identifying metabolic critical quality attributes (CQAs) of maturity will provide fundamental
insight into phenotypic maturation of iPSC-CMs, new tools to facilitate discovery of effective strategies to mature
iPSC-CMs, and novel technologies to monitor maturation state during iPSC-CM biomanufacturing. To achieve
this premise, we will employ an integrative quantitative metabolomics and proteomics approach to profile
metabolite and metabolic enzyme concentrations, and metabolic pathway utilization, in iPSC-CMs undergoing
maturation by extended time in culture or biochemical/biomechanical stimulation. Comparing metabolic
transitions during in vitro iPSC-CM maturation to metabolic transitions during development in vivo and to
acquisition of maturation phenotypes will allow us to map metabolic transitions to developmental processes. We
will perform multivariate data analyses to predict metabolic CQAs of maturation phenotypes and build novel tools
to monitor these CQAs during iPSC-CM biomanufacturing. Thus, the proposed study will provide fundamental
new insight into metabolic pathway utilization during iPSC-CM maturation and cardiac development, and will
predict metabolic CQAs that will facilitate monitoring progression of maturation in iPSC-CMs during
biomanufacturing. Our specific aims are:
1. Profile metabolic transitions during iPSC-CM differentiation and maturation. At different iPSC-CM
maturation stages induced by extended culture, micropatterned substrates, carbon source availability, and
electromechanical stimulation, we will quantify metabolite and protein concentrations via metabolomics and
proteomics and targeted metabolic assays. We will assess maturation via molecular and functional assays
to relate changes in metabolites and metabolic pathway utilization to acquisition of maturation phenotypes.
2. Assess metabolic pathway enrichment in developing murine cardiomyocytes. We will use
metabolomics and proteomics to profile metabolite and protein concentrations in murine CMs at different
developmental stages and compare to metabolic transitions that occur during iPSC-CM maturation.
3. Identify metabolic CQAs and develop tools for assessment of iPSC-CM maturity during
biomanufacturing. We will use multivariate analysis to predict metabolic CQAs that identify maturation state
of iPSC-CMs. We will then develop assays to monitor these CQAs (combinations of metabolite and metabolic
enzymes) during biomanufacturing via targeted metabolomics/proteomics, and by use of CRISPR-Cas9
gene editing to engineer reporters of metabolic pathway transitions that mark iPSC-CM maturation states.

Public health relevance
PROJECT NARRATIVE Human induced pluripotent stem cell (iPSC)-derived cardiomyocytes (CMs) offer the potential to functionally regenerate heart tissue in patients with heart disease and to evaluate drugs and other compounds for cardiotoxic effects, but iPSC-CMs lack adult phenotypes necessary to realize their promise. To overcome this roadblock, we propose an integrated metabolomic and proteomic profiling of both iPSC-CMs in vitro and cardiomyocytes in vivo to better understand metabolic transitions that occur during maturation and to predict multivariate critical quality attributes (CQAs, e.g. metabolites and metabolic enzymes) of maturation during iPSC-CM biomanufacturing. This study will provide greater insight into metabolic pathway utilization changes that occur during cardiomyocyte maturation, identify new CQAs for iPSC-CM quality, and develop tools to monitor these CQAs during cardiomyocyte biomanufacturing.